Lung-Resident Memory Th2 cells in Asthma: New Therapeutic Targets

Asthma is one of the most common chronic diseases and it is still on the rise with a prevalence estimated at 8-
9% of the U.S. population (~40 million) with an estimated cost of $50 billion/year in the US. The long-term goal
of this project is to develop new therapeutic approaches to asthma treatment that offer the potential for a long-
lasting cure, instead of merely suppressing chronic lung inflammation. Allergic asthma is the most common
asthma endotype and is thought to be driven in large part by a type 2 airway immune response to inhaled
allergens. Memory CD4+ T helper type 2 (Th2) cells initiate a recall type 2 immune response to aeroallergens
driving recurrent asthma exacerbations. A new paradigm in memory T cell biology has emerged in which tissue-
resident memory T cells (Trm) persisting in non-lymphoid tissue are critical for initiating tissue antigen-specific
recall responses. Trm are a distinct subset of memory T cells that are anatomically positioned and
transcriptionally programmed to initiate the tissue amnestic response to antigen. We and others have found that
Th2-Trm in the lung are the relevant allergen-specific Th2 cell subset that uniquely drives the cardinal features
of allergic asthma upon allergen rechallenge. The persistence of Th2-Trm in the lung drive recurrent asthma
exacerbations despite current therapies that target their mediators. The overall objective of this project is to
identify key pathways that mediate the survival and maintenance of Th2-Trm in specialized niches in the
asthmatic lung. Th2-Trm possess unique properties including increased expression of effector molecules and
specific adhesion and chemokine receptors, such as CXCR6. The central hypothesis of this proposal is that
the CXCR6 chemokine system positions Th2 cells in proximity to cells that supply survival signals for the
maintenance of allergen-specific resident memory Th2 cells in the allergic lung. Based on our preliminary data,
we hypothesize that interleukin-7 (IL7) and CCL21 produced by lymphatic endothelial cells along with CXCL16
produced by CCR7+DCs establishes a niche that provides survival signals for Th2-Trm in the lung. We also
hypothesize that inhibiting the CXCR6 chemokine system could be a new therapeutic strategy to treat allergic
asthma. We will explore these hypotheses in the following 3 specific aims: (1) To define the role of CXCR6 in
the generation and/or maintenance of allergen-specific Th2-Trm in the allergic lung; (2) To determine if inhibiting
the CXCR6 ligand, CXCL16, in the memory phase will decrease lung Th2-Trm and attenuate the recall response
to allergen and allergic airway inflammation; and (3) To define the critical survival factors in the lung niche for
the maintenance of Th2-Trm in the memory phase and extent our observations to human asthma. The proposed
research is innovative as it focuses on a novel, potentially curative approach to asthma treatment grounded in
new biology that will be explored using novel strains of mice and spatial transcriptomics of human asthmatic
lungs. These studies are significant as they will define the role of CXCR6 in Th2-Trm biology and determine if
inhibiting this chemokine system is a viable new therapeutic approach to cure chronic allergic asthma.

Public health relevance
The proposed research is relevant to public health because it focuses on providing proof of concept for new therapeutic targets for asthma therapy. Allergen-specific resident memory CD4+ T helper type 2 cells (Th2-Trm) drive the pathogenesis of allergic asthma, the most common asthma endotype. This application proposes to determine the pathways that maintain Th2-Trm in the lung and to determine if inhibiting these pathways will attenuate recurrent asthma exacerbations, which is relevant to the NIH mission to reduce illness and disability.